HBCU/MSI Mentored Research Program in the Structural Biology of Human Pathogens

Project Summary
Meharry Medical College is continuing its mission in training underrepresented minority students for diseases
that disproportionately impact underserved communities. As the COVID-19 pandemic has highlighted, infectious
diseases continue to cause a global humanitarian and economic burden. The most effective way to combat the
continued emergence of infectious diseases is to have a robust drug development pipeline at the ready. The
training for scientists in this drug development pipeline to combat infectious diseases needs to include structural
biology and students traditionally underrepresented in biomedical sciences. To strengthen professional and
scientific skills to enhance scientific productivity, particularly in the field of structural biology of human pathogens,
novel programs, such as the one proposed are needed.
The proposed HBCU/MSI Mentored Research Program in the Structural Biology of Human Pathogens is a 10-
week summer program will provide an intensive, hands-on research experience for students (community college,
undergraduate, medical) that will deliver training and education in the structural biology of infectious disease
proteins. Research training will be provided by a diverse faculty consisting of experienced structural biology
investigators from Meharry Medical College and Vanderbilt University Medical Center. A nationwide search will
be conducted to select 10-16 students per year who are interested in pursuing careers in medicine and
biomedical science related to NIAID. Student research projects will focus on structures on human pathogens,
provide by our partnership with Seattle Structural Genomics Center for Infectious Diseases (SSGCID). Student
education will encompass the fundamentals of structural biology provided in a mini-course and mentored
through the solving of protein structures. This exciting and innovative program will give each student participant
the full workflow of solving a protein structure from prediction to expression all the way through to structure
determination and publication. As a collaborator, Black In Biophysics will assign a Career Mentor to each
participant and students will participate in career development workshops to explore career options, create
individual development plans, and obtain information needed to apply and successfully gain entrance into Ph.D.
and M.D. training programs.
At the end of the 10-week program, students will have an opportunity to create oral and poster presentations
describing their research and present their research findings internally during the Summer Research Symposium
and externally at one national conference. Program directors and staff will track participants through their
undergraduate/medical and post graduate training to evaluate the extent to which program goals were met and
identify areas for improvement. Evaluations from research mentors and program directors/chairs will also be
used to assess and improve the program.

Public health relevance
Project Narrative Historically Black Colleges and Universities (HBCUs) remain critically essential in training a significant number of diverse Science, Technology, Engineering and Math (STEM) graduates. The effects of COVID-19, and other emerging public health threats continue to have an unrelenting impact on all aspects of society and will require continued development of new therapeutics to help prevent deaths, which requires a diverse representation of educators and researchers, particularly from HBCUs, to make innovative contributions in this area. The proposed HBCU/MSI Mentored Research Program in the Structural Biology of Human Pathogens at Meharry Medical College will provide a 10-week intensive, hands-on mentored research experience for students (community college, undergraduate, medical) to gain the skill of solving protein structures using X-ray crystallography.